Role of Carbon Metabolism and Virulence of Shigella flexneri

PROJECT SUMMARY (See instructions):
The long-term goal of the proposed research is to understand the adaptation of the invasive pathogen
Shigella to the human gut environment. Shigella species are associated with bacillary dysentery, a
potentially fatal diarrheal disease. With the rise in drug resistance and no effective vaccine available, the
global health burden of shigellosis, already significant, is increasing. During the course of an infection,
Shigella must transit the gastrointestinal tract, penetrate the mucous layer, and invade and replicate within
intestinal epithelial cells. To adapt these diverse environments, Shigella senses the availability of carbon
sources or products of carbon metabolism. Our hypothesis is that Shigella uses these signals to regulate
the expression of genes, including virulence genes, to maximize survival and growth in a particular niche.
A mechanistic understanding of these regulatory pathways is needed to design effective methods for
treatment and prevention of Shigella infection. We have the tools and expertise to carry out these studies.
Our work has demonstrated the importance of the alarmone (p)ppGpp, a signaling molecule produced in
response to carbon starvation, for Shigella invasion and spread in cultured epithelial cells. We will move
these studies into a model that more closely resembles the gut epithelium during natural infection. Human
intestinal organoids, or "mini-intestines", which contain multiple differentiated cell types and display an
innate immune response, will be used to study the effects of ppGpp on Shigella pathways leading to
adaptation to the host environment and virulence gene expression. Using Dual RNA-Seq, we will
determine both the Shigella and the host genes that are regulated in response to ppGpp during organoid
infection, and this will give insights into the host-pathogen interplay and guide the construction of mutants
to ascertain the relevance of both host and pathogen regulatory networks for the disease outcome.
We recently discovered that the Type I interferon beta (IFN-Beta) innate immune signaling pathway plays a
role in Shigella infection. While IFN-Beta is somewhat effective in preventing Shigella from entering host cells,
the bacteria that do get in spread more rapidly and cause larger lesions. This indicates that Shigella has a
mechanism(s) for not only overcoming IFN-Beta-induced protective responses but also hijacking the host
innate immune response to increase its virulence. We propose to use dual RNA-Seq and genetic analysis
of Shigella-infected intestinal cells to investigate how this pathogen subverts the host interferon response.

Public health relevance
Public Health Relevance: Bacterial intestinal infections are a major cause of human disease and mortality, and Shigella infections are responsible for millions of cases of dysentery worldwide per year. This research will identify the signaling mechanism that Shigella flexneri uses when infecting human cells to maximize bacterial growth and to avoid clearance by host innate immunity. These signaling pathways are promising targets for controlling bacterial infections, particularly in antibiotic-resistant strains.